A Multi-Component Model of the Self

DESCRIPTION (provided by applicant): The self-concept is viewed as a cognitive structure composed of multiple self-referent constructs (or "selves"), each of which has a distinct positive or negative valence or content and is of varying levels of importance to the individual. The level, degree, and complexity of organization and structure that these selves have within the self-concept has implications for understanding responses to environmental events, mood, information processing, and regulation of behavior. Rarely, though, are the multiple selves that compose the self-concept investigated in the context of a single study. Moreover, while issues of how the valence or content of particular selves relates to the overall structure of the self-concept have only been articulated in recent theoretical formulations, self-schema theory has not addressed how valence, content, and structure interact. Finally, most studies of the self-concept are conducted within single or perhaps a few laboratory sessions. Critical issues of how content and structure may vary over time are rarely addressed. The overall aim of this exploratory/developmental R21 application is to advance self-schema theory, specifically by analyzing how multiple self-schemas, each with varying degrees of positive and negative valence, relate to the structure and organization of the self-concept over time. We modify a theory from finance, portfolio theory, to achieve this overall aim. Portfolio theory provides an explicit means for understanding the relationship between individual components of a system and the overall structure and behavior of that system. It provides a precise model for analyzing the content and structure of the multiple self-schemas that comprise the self-concept over time, and enables detailed predictions to be made. The proposed study will follow a sample of n = 80 subjects for a period of 90 days, during which they will complete, in a secure internet-based format, surveys on the self-schemas that were activated on each of those 90 days. This rich source of data will be used (i) to test a number of central predictions of the portfolio model of the self-concept, including the role of diversification of the self-concept across selves in determining adaptation and adjustment outcomes, and (ii) to generate additional hypotheses about how the structure and content of the self-concept relate to adaptation and adjustment.